Circuit vulnerability of the lateral and medial entorhinal cortices in tauopathy models of Alzheimer's disease

Project Summary
Alzheimer’s disease (AD) currently affects ~6.7 million individuals in the U.S. alone and is expected to grow to
13 million by the year 2050. A major component of its devastation is the progressive loss of the patient’s ability
to form memories. Treatments for rescuing memory function in AD patients do not exist, due in part to insufficient
research performed to characterize the activity of memory-supporting neural circuits compromised by the
disease. The effort to develop memory-restorative therapeutics that intervene in neural circuits requires
vulnerable neuronal subtypes impacted during pathophysiological progression, and how they relate to memory
performance. Neurons in the entorhinal cortex (EC) act as a gateway for sensory inputs feeding into the
hippocampus. This EC-hippocampus circuit is critical for memory formation and retrieval. Despite its significance
to AD pathophysiology, it remains unclear which circuit components are vulnerable in the EC of AD patients or
animal models. Our laboratory’s pioneering previous research has developed exciting preliminary results that
suggest a path forward. Our overall hypothesis is that circuit vulnerability of the EC, including the lateral
entorhinal cortex and medial entorhinal cortex, to tauopathy causes associative memory impairment in AD. We
will use two Tau mouse models to identify EC cell types vulnerable to tauopathy. The project is expected to yield
advances toward the development of therapeutics to mitigate associative memory functions impaired in AD.

Public health relevance
Project Narrative No treatment currently exists for Alzheimer’s-induced impairments of memory formation, a devastating symptom contributing to the massive toll of the disease. This project will investigate vulnerable neuronal types to tauopathy using tauopathy mouse models. The project is expected to yield advances towards the development of therapeutics to rescue memory function in AD.